Integrated Support Services

The Integrated Support Services Core provides support for research done in GNL high and maximum containment. Consultation, training programs and support services include: assay development; immunology services; pathology and histology support; preclinical testing and veterinary care; imaging support and services; insectary support and services; as well as aerobiology services. The objectives of the Integrated Support Services Core during the next funding period will be to provide specialized services to support BSL4 research activities, to document costs associated with provision of these critical support services, and to design and implement sustainable cost recovery plans.

Public health relevance
The Integrated Support Services Core facilitates research in the GNL high and maximum containment labs by providing consultation, training, and support in assay development, immunology, pathology, preclinical testing, imaging, aerobiology and insectary services. Implementation of a sustainable cost recovery plan is under development to help offset service costs and maintain BSL4 research activities.